COVID-19: Role of naÃ¯ve T cells, Age associated T cell senescence, and Dysfunctional Immune regulation in host response to SARS-CoV-2

The global pandemic of SARS-CoV-2 presents the unfortunate combination of a highly contagious and highly
morbid RNA virus pathogen that is responsible for a world-wide outcome not seen since the 1917-1918 flu
pandemic. This highlights the urgent need for a vaccine that prevents or mitigates disease. Understanding the
natural host immune response to SARS-CoV-2 as it relates to clinical outcome is at the center of our current
needed perspective as we embark on preparing for the very likely, less than ideal effectiveness on initial round
vaccine. Understanding host immune response features that precede and participate in determining this
heterogeneity in clinical outcome is needed to guide us forward to an improved second round vaccine. T cell
lymphopenia may be one factor that correlates with severe COVID-19 morbidity. Certainly, both T cell and B
cell immunity are required for a successful long term response to most all viruses. Additionally, we and others
have described a number of features of host T cell immunity altered in older aged individuals with and without
viral infection, including lymphopenia, naïve T cell numerical and functional defects, T cell senescence and
deranged immune regulation. We will examine the hypothesis that: In the elderly, higher levels of IL-6 and
sTNFR2, and lower frequencies of naïve T cells preclude initial adequate T cell responses to COVID-19
infection and are also associated with lower antibody levels to prior Influenza vaccine. Senescent and
exhausted T cells and dysfunction in Tregs impair development of Th1 memory responses to SARS-CoV-2 and
predict morbid COVID-19 outcome. We will Determine whether older age, IL-6, sTNFR2, or lower naïve
CD4 T cell number/function prior to COVID-19 exposure is associated with host T and B cell response
to prior influenza vaccine and/or impaired development of effective host Th1 cell response to SARS-
Cov-2 and severity of clinical COVID-19 outcomes; and Determine whether older age and exhausted,
senescent or aberrant Treg cell phenotype present before or after COVID-19 exposure is associated
with lower SARS-CoV-2 Th1 memory response and/or host T cell and antibody response to prior
influenza vaccine.

Public health relevance
COVID-19 is a rapidly expanding global Pandemic that brings substantial morbidity to our VA patient population. There is no approved therapy or vaccine for this infection at this time. In order to improve vaccine design we will study the evolving host T cell response to this virus (SARS CoV-2) associated with varied clinical outcomes.